Kansas IDeA Network of Biomedical Research Excellence (K-INBRE)

PROJECT ABSTRACT- OVERALL
The Kansas IDeA Network of Biomedical Research Excellence (K-INBRE) is a statewide network of
graduate and undergraduate universities in Kansas and Oklahoma that work cooperatively to improve
biomedical research in Kansas. Kansas formed such a network in 2001 (Kansas BRIN) and has successfully
continued as the Kansas INBRE. The University of Kansas Medical Center (KUMC) is the Lead Institution and
works closely with 2 other Graduate Partner Institutions (GPI) (University of Kansas-Lawrence, KU-L; Kansas
State University, KSU;) and 7 institutions focused on undergraduate student training [Undergraduate Partner
Institution or UPI: Emporia State University (ESU), Fort Hays State University (FHSU), Haskell Indian Nations
University (HINU), Langston University (LU, Langston, OK), Pittsburg State University (PSU), Washburn
University (WU), and Wichita State University, WSU].
The K-INBRE is focused on 1) ethnic diversity and geographic considerations in our large but sparsely
populated state, 2) the power of mentored, team science, and 3) a skilled Kansas workforce and integration
with existing educational and training programs. The long-range objectives are to promote multidisciplinary
research networks with a focus on Cell and Developmental Biology; increase the research base and capacity
through research support; provide research opportunities for trainees; serve as a pipeline for students to
continue in health research careers; and enhance science and technology knowledge of Kansas workforce. To
achieve the objectives of the K-INBRE, the proposal contains key elements as 4 Specific Aims and 3 Cores.
Aim 1 seeks to improve the multidisciplinary research network in Kansas. The K-INBRE Administrative Core
provides oversight of all K-INBRE functions and includes the Incentives & Awards Committee and the
Undergraduate Research Office. The Communications Core focuses on network communications, scholarship
and internal evaluations. Aim 2 enhances science and technology knowledge through sophisticated
bioinformatics technology and education. The K-INBRE Bioinformatics Core continues to focus on enhanced
genomics bioinformatics, bioinformatics education, outreach and education. Aim 3 stimulates basic,
translational and entrepreneurial research in Kansas via mentored, interdisciplinary research opportunities.
The Mentoring Core oversees 2 mentoring programs and the Developmental Research Project Program.
The K-INBRE operates as a very successful program and continues to improve and expand our efforts
in Cell and Developmental Biology research in Kansas. New innovations include an expansion of our pipeline
to high school students and integration with existing educational/training programs in Kansas, as well as strong
collaborations with other IDeA (INBRE and COBRE) programs in Kansas and in the Central IDeA Region.

Public health relevance
PROJECT NARRATIVE The Kansas IDeA Network of Biomedical Research Excellence (K-INBRE) is a statewide network of Universities in Kansas and Oklahoma that work together to augment the research infrastructure, training, research productivity, and career development of biomedical researchers in Kansas. The K-INBRE has diverse programs to support researcher pipelines and research careers, build research infrastructure, and enhance the competitiveness of Kansas biomedical researchers. The strength of the program is its long-standing collaborative network, and success in pipeline development for students, trainees, and faculty in biomedical research. K- INBRE operates through four outstanding cores that have strengths in mentoring, bioinformatics, communications, and administration of this longstanding Kansas program.